Mother Centriole Appendages Regulate the AMIS Compartment and Cilogenesis

Summary Not applicable to a change of institution application.

Public health relevance
Narrative Not applicable to a change of institution application.